SKIN FOLD THICKNESS, CARDIOVASCULAR RISK FACTORS IN AMERICAN AND JAPANESE MEN

The association of different measures of obesity with cardiovascular risk factors was investigated in 946 American and 810 Japanese male telephone executives..